A Chemo-Mimetic Platform to Reprogram Metalloenzymes for Non-Natural Biocatalytic C-H Functionalization Reactions

Project summary. This proposal is for the acquisition of an Agilent Ultivo Triple Quadrupole LC/MS
System for high-throughput multiplex enantiomeric screening, aimed at developing new biocatalysts for
enantioselective non-natural transformations. The application entails justifications for this purchase and
delineates how this new instrument would facilitate our R35 research, improve the productivity of my
laboratory, and expand the new research horizons of our work. It also provides justification for the need of
this instrument as well as justification for the price of the instrument being purchased.

Public health relevance
Narrative. The development of enantioselective biocatalysts would significantly facilitate drug development processes. This application proposes the acquisition of an Agilent Ultivo Triple Quadrupole LC/MS System and its application for high-throughput multiplex enantiomeric screening, which will substantially enhance the screening capability for developing enzymes tailored to medicinally relevant enantioselective transformations for drug discovery and synthesis efforts.